Parent-Perceived Important Topics for Childhood Obesity (PPITCH)

PROJECT ABSTRACT
It is recommended that obesity counseling happen during pediatric primary care visits, but it is often infeasible
to address all recommended health and wellness topics (e.g. assessment of nutrition and physical activity
habits, motivational interviewing, setting goals) in the context of a 20-minute well child visit. Moreover, brief
counseling is unlikely to engage high-risk families who are particularly unlikely to engage in behavior change
due to cultural norms, low health literacy, and competing caregiving priorities. Best-worst scaling (BWS) is a
structured, survey-based approach that has been used to efficiently quantify patient preferences and priorities
regarding healthcare decisions while avoiding extreme response and social desirability biases. In this study,
we propose developing and fielding a best-worst scaling survey to identify and prioritize the characteristics of
obesity that parents care most about. We can therefore weed out lower priority issues that would not influence
a decision from health communication messaging. We hypothesize that focusing risk communication on the
specific obesity-related issues that are important to parents may catalyze more parents of children with obesity
to engage in behavior change to address their child’s weight status and when indicated, to engage in childhood
obesity treatment programs.

Public health relevance
PROJECT NARRATIVE Primary care visits are a key venue through which parents receive counseling about their child’s health behaviors, but it is difficult to discuss all necessary topics in the context of a single short visit. Therefore, acute issues such as vaccination and injury prevention often take precedence over long-term health conditions like obesity in well child visits. We can improve the penetrance of childhood obesity risk communication and counseling by focusing conversations on issues that parents find most concerning. By developing and administering a survey to assess and prioritize the most salient concerns parents have about their child’s health, this grant aims to improve care seeking behaviors for families of children with obesity.